Establishing a Ground Truth for Inter-Areal Neuronal Communication

PROJECT SUMMARY/ABSTRACT
This proposal focuses on the development of a powerful neural recording approach that leverages recent
technical and conceptual innovations in neuroscience— and could take them to the next level for answering
how neurons perform “computations” upon their inputs. Speciﬁcally, we propose to develop techniques for
performing dual in vivo whole-cell and large-scale extracellular Neuropixels recordings in the awake marmoset.
We will record a target cell using the powerful whole-cell technique, providing continuous, high signal-to-noise
access to the subthreshold excitatory and inhibitory inputs of the neuron (as well as its output spikes). By
pairing that recording with simultaneous extracellular measurement of 100s of neurons using a Neuropixels
probe, we will have access to an appropriately large number of possible input neurons to the target cell. We
propose to conduct our investigation in the visual cortex, leveraging retinotopic organization and a foundational
understanding of feedforward computations to perform comprehensive and physiological tests of how
information is transformed. Critically, we will conduct these experiments in the marmoset, establishing these
techniques in an exciting model system that allows for both technical and conceptual translation from rodent
model systems in one direction, and to humans in the other.
This project will establish technical feasibility and reﬁnement that would support a larger-scale, hypothesis
driven project at the R01 scale, focusing on how visual signals are transformed across the visual cortical
hierarchy and how they interact with non visual contributions coming from elsewhere in the brain (e.g., eye
movements, body movements, changes in behavioral state, etc). Because of the smooth nature of the cortex in
both marmosets and rodents, the approach we develop in this project could then used by our labs and the
larger scientiﬁc community to assess many questions across a large fraction of cortical and subcortical areas.
We further propose to share the resulting data publicly, with no delays or constraints on its use. Our dataset
will be the ﬁrst of its kind, producing new, much-needed measurements of functional synaptic connectivity
between physiologically-deﬁned neurons (i.e., mapped spatial receptive ﬁelds and visually-driven responses).
It will thus serve as a `gold-standard', `ground-truth' dataset to leverage for inferring neural connectivity from
purely extracellular recordings.

Public health relevance
PROJECT NARRATIVE The BRAIN Initiative has ushered in an exciting era of large-scale neural recordings and corresponding population-level analyses. These integrated approaches hold the promise of providing thorough characterizations of how information is transformed from one neural processing stage to the next, with the hope of building a physiological and mechanistic understanding of “neural computations”. Here, we propose to develop and utilize a novel combination of techniques that will provide major steps forward in testing hypotheses about neural computations: paired Neuropixels and whole-cell patch-clamp recordings in the visual cortices of awake NHPs.